Improving sarcopenia by targeting mitochondria

Sarcopenia, the age-related loss of skeletal muscle mass and function, predicts for morbidity, mortality and
excessive healthcare costs. Other than exercise, lifestyle therapies for slowing the progression of sarcopenia
in older men and women remain elusive. Mitochondrial dysfunction is a common mechanistic link between
aging and many pathological factors contributing to sarcopenia. We propose to test whether supplementing
the diet with an oil rich linoleic acid (LA; 18:2n6), the preferred fatty acyl constituent of cardiolipin, improves
muscle strength and physical mobility. In mice, dietary LA-rich oil increases LA-rich cardiolipin (e.g., 4-LA-
cardiolipin) and mitochondrial respiration. Therefore, the effect of LA-rich oil to increase 4-LA-cardiolipin and
mitochondrial respiration in older people with sarcopenia will be measured evaluated. Because LA is a
required nutrient for humans, e.g., an essential fatty acid that must be attained in the diet, dietary sources are
the sole method to replenish LA for cardiolipin, the signature phospholipid of inner mitochondrial membranes.
In a phase II double-blinded, randomized controlled trial, this study will test the effect of LA-oil supplementation
to change muscle strength, physical mobility, 4-LA-cardiolipin and mitochondrial function. Identifying a
mechanistic link between LA and mitochondrial capacity could aid in the development of mechanistically
targeted therapies to slow or stop the progression of sarcopenia as well as other mitochondrial-related
conditions that develop in older adults.

Public health relevance
Sarcopenia is common among older adults and may contribute to functional immobility, loss of independence and hastened mortality. This double-blind randomized controlled trial will test whether supplementing the diet with less than a serving of a linoleate-rich (LA-rich) vegetable oil per day improves muscle strength and physical mobility in older adults with probable sarcopenia. This will also be the first clinical trial to test the effect of fortifying the diet with LA- rich oil on mitochondria, a central mechanistic target could not only affect sarcopenia but other age-associated conditions: e.g., central obesity, insulin resistance, and dyslipidemia.